Vaccines for fentanyl and its derivatives: A strategy to reduce illicit use and overdose

ABSTRACT. This UG3/UH3 project will develop vaccines against fentanyl and fentanyl-like compounds as a
strategy to reduce illicit opioid use and the incidence of fatal overdoses. Proposed activities will include lead
vaccine selection and optimization, manufacturing of GMP vaccines, and IND-enabling GLP toxicology studies.
The US has seen dramatic increases in fatal overdoses due to heroin, counterfeit prescription drugs, and
cocaine adulterated with fentanyl or fentanyl-like analogs. Current medications may not be sufficient to address
the opioid overdose epidemic. As a complementary strategy to current medications, we will develop vaccines
against fentanyl and fentanyl-like compounds to reduce their abuse liability and lethality. Our team has already
developed vaccines against heroin and oxycodone that induce antibodies effective in reducing opioid
distribution to the brain, opioid-induced behaviors, and opioid-induced respiratory depression. Vaccines
effectively and selectively target the intended opioid but do not interfere with endogenous opioids nor with
approved pharmacotherapies. Opioid vaccines offer a long-lasting, safe and cost-effective intervention
complementary to medication assisted treatment (MAT). Vaccines may reduce overdoses in opioid users as
well as protect those in professions (e.g., law enforcement, airport security, postal workers) at risk of accidental
exposure to fentanyl and fentanyl analogs. Our team has identified a candidate fentanyl vaccine consisting of a
fentanyl-based hapten (F0) conjugated to the keyhole limpet hemocyanin (KLH) carrier protein, and adsorbed
onto alum adjuvant. Immunization with F0-KLH reduces fentanyl distribution to the brain, and selectively
reduces fentanyl-induced antinociception and respiratory depression in rats. We will further optimize the lead
F0-KLH by testing alternative carrier proteins. In parallel we will develop other conjugate vaccines containing a
new series of haptens (Fn) to target carfentanil, remifentanil, and other fentanyl analogs. Development will be
staggered across UG3/UH3 phases, and we expect that the first lead F0-carrier conjugate vaccine will be
ready for IND filing by the end of Year 3. AIM1 focuses on optimization of vaccines containing the lead F0
and new Fn haptens conjugated to industry-standard carrier proteins, including two E. coli-expressed carriers
obtained from our industry partner FinaBiosolutions. Leads are identified for efficacy in inducing antibodies that
will reduce fentanyl (or fentanyl analog) distribution to the brain as well as reducing antinociception, respiratory
depression and lethality in rats. AIM1 also characterizes additional immunization regimens and vaccine
efficacy in fentanyl self-administration rat models. As a contingency plan, AIM2 tests whether AIM1 leads
containing F0 and Fn haptens can be co-administered in a multicomponent vaccine formulation to
simultaneously target fentanyl and its analogs. AIM3 focuses on manufacturing of GMP vaccines and evaluate
their safety in GLP pre-clinical toxicology studies through CMO and CRO partners. AIM3 will then file an IND
for at least one vaccine formulation against fentanyl and/or its analogs.

Public health relevance
Public health narrative. The United States has seen dramatic increases in fatal overdoses due to heroin, counterfeit prescription opioids, and cocaine adulterated with fentanyl or fentanyl-like compounds. The present project will address this issue by developing vaccines directed against fentanyl and fentanyl-like compounds, offering a safe and cost-effective strategy to reduce illicit opioid use and likelihood of fatal overdose in opioid users and individuals in professions at high-risk of accidental overdoses from occupational exposure to fentanyl and fentanyl analogs (e.g., law enforcement or airport personnel). We propose to develop fentanyl vaccines, and to perform studies that would allow them to enter clinical trials.